A Physiologically Integrated Approach to Studying Mechanisms of Speech Production and Swallow Function in Down Syndrome

Abstract
Individuals with Down syndrome (DS) have substantively heightened risk of swallowing difficulties,
leading to associated risk of aspiration of food or liquid and possible pneumonia. The speech of virtually all of
these individuals can be difficult to understand by unfamiliar listeners, leading to restrictions in ability to
participate in virtually all valued activities, from educational to vocational, social, community, and self-advocacy
activities.
Production of both swallow and clear speech rely on the structures and functions of the oral mechanism
as well as their neural underpinnings. The phenotype in DS includes a spectrum of well-established
dysmorphologies in oral-pharyngeal structures and functions, in cognitive and linguistic abilities, and most
likely in neural substrate as well. Current swallow and speech interventions for individuals with DS largely rely
on recommended clinical practice approaches that are “borrowed” from other populations, such as individuals
with speech sound disorders or apraxia. Yet such individuals rarely present with the syndrome-specific
structural and functional oral-pharyngeal and cognitive/linguistic dysmorphologies seen in most if not all
individuals with DS. It is possible—even likely— that these interventions may therefore not be optimal for
individuals with DS, given that they were not designed to take into consideration the unique phenotypic profiles
in DS.
A biophysiologically integrated study of the affected domains and the relationships between them is
needed to understand the nature of impairments in DS and optimize clinical interventions. The proposed
project will examine the mechanisms of swallow and speech production directly within the context of the
documented phenotypic characteristics in DS. Specifically, we will examine the interrelations between domains
of oropharyngeal structure, muscle strength, somatosensation, measures of cognition, perception and
language, and the underlying neurology in terms of how each relates to the execution of the oral motor
behaviors of swallow and speech production. The research team brings together experts across each of the
planned domains, all at the same institution, led by a PI whose career has been dedicated to application of
innovative measurement techniques to individuals with intellectual and developmental disabilities, including
DS.

Public health relevance
Project Narrative Individuals with Down syndrome (DS) have well-documented syndrome-specific atypicalities in oral- pharyngeal structure and function, which are believed to be linked to heightened risk for swallowing disorders (and resultant sequalae such as aspiration-linked pneumonia) as well as difficulty producing clear speech (which can limit opportunities to engage in educational vocational, social, and community activities). Current swallow and speech interventions in DS largely rely on clinical practice approaches that are “borrowed” from other populations, such as individuals with speech sound disorders or apraxia, who rarely present with the syndrome-specific dysmorphologies seen in DS. The proposed project will conduct an integrative analysis of the interrelations between phenotypically-linked characteristics of oropharyngeal structure and function, cognitive and linguistic functioning, and the underlying neurology to determine the mechanisms underlying the execution of oral motor behaviors of safe swallow and clear speech in DS.